Detecting pathogen and host factors on extracellular vesicles for pediatric TB diagnosis and management

ABSTRACT
Tuberculosis (TB) is a major cause of pediatric morbidity and mortality (1.2 million new cases and 224,000
deaths in 2021), with most deaths occurring in children < 5 years who do not initiate treatment. These children
often present with disseminated or extrapulmonary TB as their immune systems may fail to contain their M.
tuberculosis (Mtb) infections in their lungs. Since host responses play critical roles in TB development, analysis
of Mtb- and host-derived could improve early diagnosis and TB management. However, TB tests still primarily
rely on microbiologic evidence from respiratory samples that are difficult to obtain from, and less informative for,
young children. Sputum culture detects only 30-60% of pediatric TB, and similar results are obtained with PCR-
based Xpert MTB/RIF and Xpert Ultra assays. There is thus an urgent need for non-sputum-based tests that can
effectively diagnose pediatric TB and monitor its response to treatment.
Serum biomarker assays are ideal for pediatric TB diagnosis. The assay used in our initial proposal detects
low abundance Mtb proteins in serum to effectively diagnose pediatric TB and has since received breakthrough
device status by the FDA prior to pending validation studies for its FDA clearance. We have further shown that
we can employ a nanoparticle-enhanced immunoassay (NEI) read by an inexpensive portable device to detect
Mtb-derived factors on extracellular vesicles (EVs) for TB diagnosis, an approach suitable for use in resource-
limited settings. We have also shown that a simple modification can markedly increase sensitivity and
reproducibility to improve measurements. Biomarkers on EVs secreted by Mtb-infected phagocytes and by
immune cells may reflect Mtb burden and its containment by the immune system, and provide critical information
to required improve pediatric TB diagnosis and to allow rapid and accurate assessment of effective anti-TB
treatment. However, few studies have evaluated the diagnostic and prognostic performance EV-based Mtb
assays, and none have evaluated the ability of host-derived EV biomarkers to improve assay performance.
We now propose modify our initial NEI test to incorporate both Mtb- and host-derived EV markers associated
with TB disease in order to enhance its performance for TB diagnosis and treatment monitoring. We will employ
the following aims to develop and characterize this modified assay: 1) We will optimize its EV biomarker signature
using additional Mtb- and host-derived proteins we will identify from serum EVs of TB cases and controls. 2) We
will conduct an analytical validation of this refined NEI to establish its characteristics using STARD guidelines.
3) We will establish a prediction model of NEI array’s multiplex performance for TB diagnosis and treatment
evaluation using longitudinal serum and data from a retrospective cohort of HIV-exposed infants at increased
risk for TB (IMPAACT P1041 cohort) with longitudinal samples. 4) We will validate the NEI array’s ability to
diagnose LTBI and active TB and evaluate the efficacy of anti-TB treatment responses using longitudinal serum
from a second cohort of older children prospectively enrolled at the O&M Hospital in the Dominican Republic.

Public health relevance
NARRATIVE Current tuberculosis (TB) tests have reduced sensitivity when applied to diagnose young children who may develop more rapid and severe disease due to their immature immune systems, and this can delay or prevent the initiation of appropriate anti-TB treatment and result in more severe disease or death. Our initial proposal developed a blood-based biomarker assay that read by a mass spectrometer that sensitively detects proteins release by M, tuberculosis (Mtb) to diagnosis TB even in diagnostically challenging pediatric populations, and we now intend to expand upon this experience to develop a streamlined assay that is read by an inexpensive portable device that can be used in resource-limited settings where TB is often prevalent. This assay will detect proteins on extracellular vesicle (EV) secreted by Mtb-infected phagocytes and by immune cells to evaluate Mtb burden and its containment by the immune system, and thus provide critical information about pathogen-host interactions required improve pediatric TB diagnosis and to allow rapid assessment of the effectiveness of TB treatment.